Mechanisms of endosomal trafficking in lipid droplet catabolism

Project Summary/Abstract
The purpose and scope of this supplement is to purchase a Nikon AXR resonant scanning confocal microscope
to accelerate the research of the parent R35 ESI MIRA (GM150801). The purpose of the parent R35 is to
investigate the cellular mechanisms responsible for the trafficking of lipid droplets during lipophagy. In Project 1,
we will determine the role of adipose triglyceride lipase (ATGL) in remodeling the lipid composition the LD surface
monolayer via triglyceride hydrolysis. In Project 2, we will investigate the role of Rab5 in recruiting PI 3-Kinases
to the LD surface to phosphorylate PI, as well as define the role of ESCRT proteins in the trafficking of LDs for
lipophagy. As these studies rely heavily on fluorescence microscopy, the acquisition of a high-resolution confocal
microscope will greatly enhance our ability to visualize these small subcellular organelles and accomplish the
goals of this award.

Public health relevance
Project Narrative This project is addresses basic mechanisms that mediate lipid droplet catabolism and biogenesis, both of which are critical for fundamental cellular processes. Because LD catabolism is dysregulated in multiple diseases including fatty liver, obesity, diabetes, kidney disease and cancer, elucidating these mechanisms creates an opportunity to identify targets in LD catabolism that and improve human health.